ALD Healthy Planet Project

X-linked adrenoleukodystrophy (ALD) is a fatal peroxisomal disorder characterized by three distinct
phenotypes: cerebral ALD (cALD), adrenomyeloneuropathy (AMN), and Addison’s only (adrenal insufficiency or
AI). In 2016, ALD was added to the Recommended Uniform Screening Panel (RUSP), and it has been
implemented to date in 36 states and Washington DC. ALD poses a unique challenge in newborn screening
follow up. While treatments for cALD and AI are effective and life-saving, they are only implemented once there
is evidence of disease involvement. In the case of cALD, there is a narrow window for intervention that is limited
to the earliest phase of disease. This has created a major challenge—boys identified via newborn screening
must be intensely followed throughout childhood by serial brain imaging and by endocrinologic testing.
There is an urgent unmet need for a rigorous automated system to track compliance with recommended
follow up testing. We will leverage our existing Rare Diseases Clinical Research Network (RDCRN) Global
Leukodystrophy Initiative Clinical Trials Network (GLIA-CTN; U54TR002823) to deploy this system and measure
its efficacy. In Aim 1, the CHOP Healthy Planets EPIC programming team, who originally developed the ALD
monitoring dashboard in collaboration with the CHOP Leukodystrophy Center of Excellence will work with local
EPIC programmers at Children’s Hospital of Atlanta, Stanford Children’s Health, and Kennedy Krieger Institute,
sharing code and facilitating the adaptation of the CHOP system to local EPIC environments. The expected
outcome is a functional ALD monitoring dashboard and an open-access manual on how this approach can be
more broadly implemented to additional sites. In Aim 2, we will establish the data collection pipeline to establish
data-driven monitoring guidelines. Leveraging the existing electronic health records program within the GLIA-
CTN, we will establish the data pipeline for centralization of ALD-monitoring. We will collect and curate the data
across the GLIA-CTN implementation sites. The expected outcome is a curated data pipeline and generation of
pilot data to understand if existing monitoring guidelines are appropriate for a post newborn screening ALD
population. The expected outcome is generation of data collection tool necessary to establish evidence-based
post newborn screening guidelines.
While the ALD field has been transformed by early detection and ground-breaking therapies, there is an
urgent, unmet need for system to monitor compliance with long term monitoring needs. This pipeline can support
presymptomatic natural history studies and establish standard of care monitoring guidelines that are data-driven.
The proposed work is both clinically necessary and will help to support future hypothesis-driven work. This
strategy has the potential to improve health equity, ensuring that decreased access to care does not equal
decreased safety and monitoring. Additionally, the general approach can be adapted to other newborn screening
programs and rare disorders with complex longitudinal monitoring needs.

Public health relevance
Narrative Emerging therapies in the leukodystrophies make it imperative to establish a reliable and disseminated resource for biosamples in this group of disorders. The Global Leukodystrophy Initiative (GLIA) proposes to to create a newborn screening monitoring platform for adrenoleukodystrophy. In this proposal, we will create the necessary infrastructure for the GLIA RDCRN funded consortium.